Gynecologic cancer care: Improving clinical trial enrollment through molecular matching with targeted therapies and improving equal access to care and research for all populations

Project Summary/Abstract
Gynecologic Cancer remains an underfunded area of research with funding to lethality scores significantly lower
than other cancer sites. Endometrial cancer, the most common gynecologic cancer, is one of the few cancers
that has seen an increase in incidence and mortality over the recent years, with black women and minorities
disproportionally affected. Underrepresented populations often develop high risk and rare subtypes of uterine
cancers with distinct molecular profiles. Recent research has identified several molecular subtypes that can be
targeted with novel agents, however, most of these studies have low enrollment of underrepresented populations
who are most likely to have the greatest benefit.
Molecularly driven trials are critical to the progress of personalized medicine to improve survival and limit
exposure to ineffective therapy and associated toxicities. Unfortunately, these highly specialized clinical trials
are at risk of failure due to slow accrual or under-enrollment of the appropriate populations. As the national PI
for NCI/NRG-GY020 (vaginal brachytherapy +/- immunotherapy for early stage high risk mismatch repair
deficient endometrial cancer, which is a subset of endometrial cancer patients who are highly sensitive to
immunotherapy) Dr. Backes is well aware of the opportunities and challenges associated with molecularly driven
clinical trials. NCI support through the R50 mechanism will allow Dr. Backes to increase her efforts to
improve enrollment to clinical trials for all populations, both at her institution and nationally. First,
leveraging the resources of the Ohio State University Comprehensive Cancer Center (OSUCCC), Dr. Backes
will develop a comprehensive system for molecular matching to simplify and streamline the identification of
patients for trials and specialized trials for patients, which will increase accrual. Collaborative cross-disciplinary
efforts are especially important with the increasing complexity of molecularly driven clinical trials, such as NCI
ComboMatch and iMatch, and also to improve the outcomes of patients with rare tumor mutations. Secondly,
Dr. Backes will collaborate with Dr. Elektra Paskett to include gynecologic oncology on a recently opened study
“OSU Connecting Underrepresented Populations to Clinical Trials” (1U01CA274999-01). Dr. Backes and Dr.
Ashley Felix (PhD, Epidemiology) will focus on assessing barriers and implement strategies to improve access
to care and clinical trials for underrepresented populations in gynecologic oncology locally and nationally. Finally,
the opportunities afforded by this award will allow Dr. Backes to increase her time to design and support the
development of paradigm shifting clinical trials, and mentor junior investigators in this process, through
her national roles as the NRG Oncology Co-Chair for Developmental Therapeutics, member of the Uterine
Corpus Committee, New Investigator Committee, NCI Uterine Taskforce, national PI for NRG-GY020 and other
trials under development, and in additional local roles as the Disease Specific Research Group Leader, NRG
Oncology site PI for Gynecologic Oncology and Fellowship Director.

Public health relevance
Project Narrative Dr. Floor Backes is exceptionally passionate about improving outcomes of all patients through participation in clinical trials with equal access to care and research. This award would support Dr. Backes to work within NRG Oncology continue to design, develop, and support novel paradigm shifting clinical trials as principle investigator, mentor, Co-Chair of the NRG Oncology Developmental Therapeutics (DT) committee, member of the Uterine Corpus Committee, and NCI Uterine Taskforce. Local institutional goals are to support the Ohio State University and James Comprehensive Cancer Center to develop a comprehensive system for multidisciplinary collaboration and molecular matching increase enrollment to NCTN trials and especially to disease agnostic molecular driven trials, streamline trial implementation and to increase the referral and accrual of racial/ethnic minorities to NCI’s National Clinical Trials Network (NCTN) prevention/control and treatment trials.